Core Center for Musculoskeletal Biology and Medicine

The goal of the Administrative Core is to provide: 1) leadership for the CCMBM research base; 2)
administrative management, fiscal oversight, and reporting all CCMBM activities; 3) coordination and integration
of CCMBM communications; and 4) management of the Enrichment Program, including the Pilot/Feasibility grant
program and the Tools and Technology grant program. The Administrative Core will be led by a Director (Lotz)
and Associate Director (Nissenson) who are assisted by an Internal Executive Committee, an Internal Advisory
Board, and an External Advisory Board.

Public health relevance
PROJECT NARRATIVE Not Applicable